Endothelial biomechanics in vascular aging

Endothelial biomechanics plays a key role in multiple endothelial functions. Our earlier studies discovered that
oxidized lipids in vitro and dyslipidemia in vivo induce significant endothelial stiffening via CD36 scavenger
receptor and incorporation of oxysterols. Most recently, we found that endothelial stiffening in aging aortas
critically depends on CD36 and the caveolar protein, Caveolin-1 (Cav1). Our long term goal is to elucidate the
mechanisms responsible for age-induced changes in endothelial biomechanics and to determine the
contribution of these mechanisms to endothelial dysfunction. In the current proposal, we address three goals:
In Aim 1, we focus on elucidating the mechanism of age-induced EC stiffening. First (1A), we will determine
whether endothelial-specific deletions of CD36 and/or Cav1 prevent endothelial stiffening in moderately aged
(10-12 months old) and advanced aged (20-24 months old) mice and whether expression/membrane
localization of these proteins is altered by age. Then (1B), we will provide a comprehensive lipidomics analysis
of changes in lipid composition in arterial tissues with age and identify specific lipid species that accumulate
with age and induce endothelial stiffening. In Aim 2, we focus on age-related actin remodeling and disruption of
endothelial barrier integrity. First (aim 2A), we will determine the roles of endothelial CD36 and Cav1 and
CD36/Cav1-mediated uptake of oxidized lipids in age-related actin remodeling, junctional morphology,
endothelial permeability to macromolecules, and infiltration of monocytes. In the second part of the aim (2B),
we will investigate the molecular mechanisms by which oxidized lipids, particularly oxysterols, induce actin
remodeling, focusing on a novel hypothesis that oxysterols compete with RhoA for binding to a RhoA inhibitory
protein, GDI-1. In Aim 3, these studies are extended to investigate the impact of CD36/Cav1/oxysterol-
dependent endothelial stiffening in inducing distortion of nuclear morphology, DNA damage and nuclear
translocation of mechanosensitive transcription factors (3A) and explore the hypothesis that oxysterol-induced
endothelial stiffening results in nuclei distortion by disruption of a peri-nuclear structure called the actin cap
(3B). These studies are then extended to an exploratory sub-aim (3C) of comparative analysis of
transcriptomic changes in aged endothelium in vivo and in endothelial cells exposed to oxidized lipids that
induce endothelial stiffening. These goals are achieved using endothelial-specific loss of function (CD36 and
Cav1) and gain of function (Cav1) genetic mouse models. A combination of Atomic Force Microscopy, lipid
mass-spectrometry, high resolution confocal imaging analyzed by machine-learning algorithms and other state-
of-the-art experimental approaches. Taken together, these studies are expected to provide significant new
insights into our understanding of the mechanisms responsible for endothelial stiffening in aging vasculature
and the role of lipid-induced endothelial stiffening in age-related barrier disruption and nuclei abnormalities.

Public health relevance
Arterial stiffening is recognized to be central in the process of vascular aging, deterioration of vascular function with age, but the role of endothelial stiffening is still not well understood. We discovered that the stiffening of the endothelial monolayer, the inner layer of the arteries, with age critically depends on a receptor known to be responsible for the uptake of oxidized lipids. In this study, we propose that endothelial stiffening induced by the uptake of oxidized lipids drive vascular inflammation and result in the damage of nuclei leading to genomic instability, a hallmark of aging.